Molecular Mechanisms of Invariant Natural Killer T Cell Differentiation

Project Summary
Invariant Natural Killer T (iNKT) cells are T lymphocytes that express a semi-invariant T cell
receptor (TCR) and exist in a primed effector state capable of making numerous cytokines
within minutes after activation. iNKT1 cells develop in the thymus and migrate as immature cells
to peripheral lymphoid and non-lymphoid organs where they reside as tissue-resident sentinels
that protect against invading pathogens. Here we describe the transcription factor Ets1 as a
central regulator of the development, adhesion, migration, and NK cell-associated gene
programs of iNKT1 cells that control their tissue residency, localization, and function. We
propose experiments to investigate the relevance of these programs to iNKT1 cell development,
trafficking, location and function as well as experiments to identify the molecular basis for Ets1-
mediated regulation of these programs in the thymus, liver and spleen. Given the conservation
of tissue residency and adhesion programs across lymphocytes, we propose that our data will
provide not only significant insight into the mechanisms controlling iNKT1 cell location but also
in other innate and adaptive lymphocytes.

Public health relevance
Relevance iNKT cells are tissue resident innate-like immune cells that are implicated as both positive and negative regulators of disease. Understanding the mechanisms controlling their development, tissue residency, and effector function is of fundamental importance but will also support future immunotherapeutics designed to traffic to specific tissues.